The Impact of Cigar Pack Quantity on Tobacco Use Behavior

PROJECT SUMMARY
This K01 application is designed to provide Jessica King, PhD, with the mentored training necessary to
transition into an independent tobacco regulatory science researcher. Dr. King will be mentored by a team of
renowned tobacco control and tobacco regulatory scientists and will complete mentored training, coursework,
and professional development in the areas of advanced statistical analyses, policy impact analyses, and health
disparities. This additional career development and mentorship will directly contribute to completing the
proposed research strategy, which examines the impact of cigar pack quantity on tobacco use behaviors. Cigar
use is the third most commonly used tobacco product among adults, and second most commonly used product
among youth, with use increasing among low income, minority, and young adult populations. Given the
significant health effects attributable to cigar use, this represents a critical health disparity. Low cost is often
cited as a reason for increased use among these populations, in part due to low taxes and varying pack
quantities. Research on cigarettes has shown minimum pack quantity laws increase price and decrease use.
As of 2016, the FDA has regulatory authority over cigars, allowing it to regulate the marketing, manufacturing,
and distribution of cigar products, including mandating minimum pack quantities. However, cigar-specific data
are needed to inform FDA's regulation. Thus, the goal of the proposed analyses are to advance understanding
of the relationship between cigar pack quantity and tobacco use behaviors to inform regulation on minimum
cigar pack quantity. Specifically, we aim to (1) assess whether cigar pack quantity is associated with between-
and within-person changes in cigar use and whether there are differences by sociodemographic factors, (2-3)
identify the impact of local minimum cigar pack quantity laws on cigar and other tobacco use and cigar sales
and whether impacts differ across communities of varying demographics, and (4) characterize differences in
the implementation and enforcement of minimum cigar pack quantity laws through qualitative interviews with
key implementation personnel. In this mixed-methods approach, we will utilize national datasets, including the
Population Assessment of Tobacco and Health Study, the Tobacco Use Supplement to the Current Population
Survey, the Youth Risk Behavior Surveillance System, and Nielsen retail scanner data. Each aim will explicitly
examine the impact among racial and ethnic minorities, low income populations, youth, and young adults, each
vulnerable populations. This research will directly address the FDA Center for Tobacco Products Scientific
Domains of behavior and impact analysis. The findings from this study may inform future FDA rulemaking on
cigar pack quantity.

Public health relevance
PROJECT NARRATIVE Cigar use is a significant public health concern, particularly among vulnerable populations. The proposed longitudinal and policy impact analyses will examine the impact of cigar pack quantity on tobacco use behaviors. This research will directly address the FDA Center for Tobacco Products Scientific Domains of behavior and impact analysis, and findings may inform future FDA rulemaking on cigar pack quantity.